Benzodiazepine mediated mechanisms of transcriptional semi-quiescence in discrete myeloid populations

One of the principal obstacles to curing HIV is the existence of viral reservoirs in distinct compartments and
cell types that are unaffected by antiretroviral therapy (ART). In the central nervous system (CNS), these
reservoirs are comprised of myeloid cells, such as perivascular macrophages and microglia. Critically, these
reservoirs are generally established prior to the initiation of ART and the presence of ART in the CNS does not
affect the established reservoir in long-lived myeloid populations. Thus, even in individuals on suppressive ART,
persistently infected CNS macrophages and microglia can drive ongoing neuroinflammation and provide a
source of HIV for viral recrudescence during medication hiatus or failure. Our ability to eliminate these reservoirs
is severely limited by the lack of understanding of the transcriptional and epigenetic regulation of HIV in myeloid
cells. To effectively target and eliminate CNS reservoirs in people living with HIV (PLWH), it is critical to define
the transcriptional mechanisms mediating persistent infection in distinct CNS myeloid populations.
The impact of HIV infection in the CNS is heightened in PLWH who have substance use disorders, including
those who take and/or misuse therapeutic drugs such as benzodiazepines (BDZ). Benzodiazepines are used by
more than 30 million Americans, have high abuse liability and misuse of these drugs accounts for 15 – 20% of
their use. Benzodiazepines are prescribed to a growing number of PLWH and are associated with an increased
risk of neurocognitive symptoms in this population. Little is known about the mechanisms by which BDZ impact
HIV neuropathogenesis. Our published and preliminary data indicate that BDZ can alter the transcriptional
regulation of HIV infection. To better understand and treat the development of neuroHIV in PLWH who use and/or
misuse BDZ, it is vital to determine who benzodiazepines affect the transcriptional programs in myeloid cells.
We hypothesize that both macrophages and microglia enter a semi-quiescent transcriptional state
during ART exposure and that benzodiazepines disrupt this state and increase transcriptional activity
and viral replication. Our data show that the BDZ Xanax, as well as some latency reactivation agents, mediate
a dose-dependent increase in p24 production in infected, ART-treated cells. Our preliminary studies suggest
these effects may result from BDZ interactions with the epigenetic regulator RUNX1. We posit that these changes
in HIV replication in myeloid cells reflect the epigenetic state of the provirus. Thus, the growing population of
PLWH who use BDZ is at greater risk of more severe neuropathogenesis. It also suggests that BDZ may provide
the basis for novel therapeutics to manipulate HIV transcription in myeloid cells. Therefore, we will evaluate the
transcriptional and epigenetic mechanisms sustaining the semi-quiescent state of HIV transcription in ART-
treated human macrophages (Aim 1), define the differences in transcriptional and epigenetic processes in
different types of myeloid cells using human syngeneic iPSC-derived macrophages and microglia (Aim 2), and
examine the effect of benzodiazepines on transcription HIV-infected, ART-treated myeloid cells (Aim 3).

Public health relevance
Persistent HIV replication in populations of macrophages and microglia in protected anatomical compartments like the brain is a central impediment to successfully curing HIV. This problem is heightened among vulnerable populations with substance use disorders, including misuse of therapeutics such as benzodiazepines which exacerbate neuroHIV. This proposal will address these issues by defining the transcriptional processes regulating HIV replication dynamics in myeloid cells and evaluating how epigenetic factors such as RUNX1 are involved in benzodiazepine mediated increases in transcription and replication.